EFFECTS OF PHORBOL ESTER ON PRODUCTION OF AMYLOID PROTEIN PRODUCTS: ALZHEIMERS

The effects of phorbol ester on amyloid protein products were investigated using our new immuno-affinity mass spectrometric assay.